Defining the Biochemical Function and Therapeutic Utility of Unique PARP14 and PARP15 ADP-Ribosylation Sites

SUMMARY
ADP-ribosylation was one of the first post-translational modifications (PTMs) discovered. It is a widespread and
ubiquitous post-translational modification across all kingdoms of life – whose biochemical selectivity, cellular
consequences, and final fates remain poorly understood. Our objective is to investigate the entire life-cycle of
the ADP-ribose modification; from ADP-ribose transfer, to the post-transfer alterations of that ADP-ribose, and
the final removal of the resulting PTMs. We will use our findings to investigate the functions of the ADP-ribose
signal transduction network and develop first-in-class peptide-based inhibitors to target malfunctioning ADP-
ribose signaling networks. In humans, 17 different poly-ADP-ribose polymerases (PARPs) catalyze ADP-
ribosylation, a separate set of enzymes convert ADP-ribose to phosphoribose, and 6 glycohydrolases remove
ADP-ribose. Importantly, there are a multitude of glycohydrolases found in various viral species. The enzymes
associated with ADP-ribose processing have been implicated in a variety of physiological functions (e.g., DNA
repair, RNA regulation, cell development) and a broad array of diseases, most notably viral infection. While
previous efforts have validated the roles for PARPs 14 and 15 in viral regulation, their mechanism of action
remains unclear. In large part, this lack of clarity arises from our inability to connect a single site of ADP-
ribosylation to its downstream function. Work in the kinase field has demonstrated the power of connecting
enzyme-specific PTMs to their precise cellular function, fundamentally altering our understanding of signal
transduction and revealing new avenues for therapeutic intervention in disease. By leveraging the expertise
from my lab and that of my collaborators, our work will use a multidisciplinary approach to determine
the functional consequences of unique ADP-ribosylation events in the cell and develop novel viral
glycohydrolase-selective peptide-based inhibitors to block specific ADP-ribose removals. In the first aim,
we will identify the auto-modification sites on PARP14 and PARP15, linking specific ADP-ribosylation sites to
cellular effects. We have extensive experience working with these PARPs and we have a robust viral model to
interrogate how specific site alterations change pathway behavior. In the second aim, a PARP14-specific target
peptide sequence that we have developed will serve as a platform to identify selective viral glycohydrolase
inhibitors. We will synthesize peptide and peptoid (poly-N-substituted glycine) derivatives of the initial target
peptide and identify structure activity relationships (SAR analysis) with the resulting library to optimize promising
antivirals. In the third aim, we will map the biochemical pathway responsible for converting ADP-ribose to
phosphoribose. We will identify the phosphoribose interactome and investige its role in the innate antiviral
response. This research will enhance our mechanistic understanding of ADP-ribosylation and offer new
strategies for targeting viral glycohydrolase enzymes, with broader implications for studying PARPs,
glycohydrolases, and ADP-ribose processing in medicine and cell biology.

Public health relevance
PROJECT NARRATIVE ADP-ribosylation is a ubiquitous post-translational modification that is regulated by poly-ADP-ribose polymerases (PARPs) that add ADP-ribose to target proteins, glycohydrolases that erase ADP-ribose, and a growing number of ADP-ribose processing enzymes which alter ADP-ribose. These enzymes have been implicated in a number of physiological and pathophysiological functions – including cell development, viral infection, and cancer progression – but the links between unique ADP-ribosylation events and their downstream effects are unknown. The proposed work will define the role of specific ADP-ribosylation modifications during viral infection while developing novel peptide-based inhibitors as probes and therapeutics to selectively block viral glycohydrolase activity.